Equipment Purchases for Breathitt Veterinary Center

Project Summary/Abstract
CVM Vet-LIRN Veterinary Diagnostic Laboratory Program
PAR-22-063
Breathitt Veterinary Center (BVC) seeks funding to maintain the high quality level
of testing through participation in the CVM Vet-LiRN Veterinary Diagnostic Laboratory
Program.
This funding will be used for the following:
•Maintain BVC's Antimicrobial Resistance Study participation
•Maintenance Contract for equipment
•Fund Proficiency Testing by BVC lab sections
•Training for BVC staff
•Travel by BVC staff to training sessions, appropriate meetings and conferences
•Membership dues for scientific organizations

Public health relevance
Project Narrative CVM Vet-LiRN Veterinary Diagnostic Laboratory Program (U18) PAR-22-063 Breathitt Veterinary Center (BVC) will utilize funding from this program to improve the quality of testing by staff members through proficiency testing and staff training. Funding will also support the Antimicrobial Resistance Study being conducted at BVC in collaboration with other labs in the Vet-LiRN network and provide a maintenance contract for the SensiTitre instrument.